REPEATED DOSES OF LJP 394 IN PATIENTS WITH SLE NEPHRITIS

The primary objective of this research study is to determine whether LJP 394 is more effective than placebo in preventing renal flare in patients with a prio history of lupus renal disease.